Molecular function of extracellular vimentin in regulating the response to lens wounding

The vimentin intermediate filament cytoskeleton can quickly sense and respond to stress in the environment,
and under certain conditions become altered through post-translational modifications (PTMs) to alter its
function and disassemble into soluble oligomers for extracellular release. Extracellular vimentin (eVim) has
emerged as a regulator of both physiological and pathological processes, however we lack an in-depth
understanding about the molecular mechanisms that regulate eVim function. Using an ex vivo post-cataract
surgery model that recapitulates the major features of the lens fibrotic disease, posterior capsule opacification,
our studies revealed a role for extracellular, cell-surface vimentin in promoting wound healing and fibrosis. In
response to cataract surgery wounding, eVim became released into the extracellular environment, bound to
the cell-surface of myofibroblast progenitor cells, linked to causing fibrosis and promoted a fibrotic response to
lens injury. The objective of this proposal is to decipher the molecular mechanisms by which eVim drives a
pathological fibrotic outcome to lens injury. The central hypothesis is that lens wounding stimulates alterations
to the cellular environment leading to the activation of factors that cause changes in intracellular vimentin
leading to the release of eVim into the extracellular space, and in the process vimentin has acquired a distinct
structural form and molecular characteristics that shape eVim pro-fibrotic function, including the ability of eVim
to bind to the cell surface of myofibroblast progenitor cells and signal a pathological outcome to lens injury. The
rationale fundamental to this proposal is that completion of these studies will provide important new insight into
the molecular regulation of eVim function in driving fibrosis that can be applied to understanding eVim function
in other pathogenic processes. The proposed work will also identify key aspects of eVim regulation that may be
targeted to prevent a fibrotic outcome to lens injury. The central hypothesis will be tested in the following three
specific Aims: 1) Investigate mechanisms mediating vimentin release into the extracellular space and cell-
surface binding post-lens wounding, 2) Investigate the mechanisms by which extracellular vimentin signals
fibrosis in the lens and 3) Investigate the state of extracellular vimentin linked to driving lens fibrosis post-
injury. We will pursue these aims using an innovative combination of molecular and biochemical techniques,
including vimentin-linked polyacrylamide gels, a novel tool developed to study how eVim interacts with the
surface of cells. The proposed research is significant, because there is a lack of comprehensive
understanding about the conditions that regulate vimentin release by cells, binding of eVim to the surface of
cells, and the eVim-dependent signaling intermediaries that promote fibrosis. It is also significant because the
specific oligomeric form(s) and modifications that eVim adopts to modulate its function to drive lens fibrosis are
elusive. The expected outcome of this work is to provide new insight into the molecular details regarding how
eVim function in wound healing becomes altered to induce a fibrotic outcome to lens injury.

Public health relevance
A major undesirable outcome of cataract surgery wounding is the development of the lens fibrotic disease, Posterior Capsule Opacification (PCO). The proposed studies take important steps toward elucidating how extracellular cell-surface vimentin functions to promote a fibrotic response to lens injury. Findings from these studies are expected to inform new treatment strategies for PCO, with potential application to understanding how extracellular vimentin mediates fibrotic disease and pathogenesis in other tissue types.